An ER Stress Inducible START Domain Cholesterol Transport Protein, StarD5; and Unique Role in Fatty Liver Disease

Fatty liver disease is an inflammatory response to accumulation of toxic metabolites within the
liver. In the United States, the progression of fatty liver disease to liver inflammation → fibrosis →
cirrhosis will soon be the leading cause of liver transplantation, especially within the Veteran’s
population; creating a challenge for our country’s Health Care budget. The molecular basis of
nonalcoholic fatty liver disease (NAFLD) is incompletely understood. Recent findings provide
strong evidence abnormal cholesterol metabolism drives the transition from fatty liver to
inflammation initiated by ER stress pathways. StarD5, a member of the StarD4 subfamily of
proteins that contains a characteristic START domain, is a soluble protein that binds and
translocates cholesterol within the cell. StarD5 is ‘upregulated’ by endoplasmic reticulum (ER)
stress, which makes it a candidate to play a key role in the carrying of cholesterol out of the ER
to maintain ER integrity. We have shown in preliminary observations shown that lack of StarD5
in hepatocytes can lead to a decrease in plasma membrane (PM) cholesterol and fluidity, an
increase in cholesterol and its potential inflammatory metabolites, a decrease in neutral lipid
(triglyceride) secretion, an increase in neutral lipid accumulation (triglycerides), subsequent
development of insulin resistance, and progression to steatohepatitis and ensuing transcriptional
activation of fibrotic pathways. Furthermore, the storing of higher levels of cholesterol and
triglycerides in StarD5-/- mouse livers, which is markedly exasperated with Western diet feeding,
leads to altered expression of cholesterol-regulated genes. Conversely, preliminary studies show
StarD5’s restoration in StarD5-/- livers, using an AAV9-StarD5 liver-selective overexpression
vector, is capable of reversing changes and protecting against ER stress. These observations
demonstrate an ‘adaptive protective role’ of StarD5 in NAFLD. Lipids, including cholesterol, have
been shown to be moved between membranes by non-vesicular lipid transfer proteins (LTP),
transfer that it is fueled by Phosphatidylinositols (PIPs). LTPs that target the ER have an FFAT
motif (diphenylalanine [FF] in an acidic tract [AT]) that interact with ER proteins. We have
identified a potential FFAT motif in the StarD5 protein that is conserved among species. In cells
transfected with the FFAT motif mutated, StarD5 does not interact with the PM, cells have less
accessible PM cholesterol, and, upon PIPs incubation, cells do not increase PM cholesterol as
they do in cells transfected with the WT StarD5. We hypothesize that StarD5 functions in the
physiologic maintenance of cholesterol homeostasis by moving cholesterol out of the ER. In
doing so, in cells with high or readily inducible levels of cholesterol, like hepatocytes, it prevents
accumulation of cholesterol and neutral lipids by moving cholesterol to the PM and potentiating
lipoprotein assembly and secretion. We propose to 1) characterize the role of StarD5 in the
intracellular movement of cholesterol in hepatocytes, including its role in VLDL assembly and
secretion; 2) characterize the molecular mechanisms involved in the transfer of StarD5-mediated
cholesterol; 3) characterize the in vivo role of StarD5 in the development of fatty liver disease.
The proposed studies will likely unveil a novel biologic pathway showing StarD5 plays a key role
in maintaining physiological cholesterol levels within the ER, inhibiting lipid accumulation, and
providing protection against the development of fatty liver disease.

Public health relevance
Fatty liver disease is an inflammatory response to accumulation of toxic metabolites within the liver. In United States Veterans, the progression of fatty liver disease to liver inflammation/fibrosis/cirrhosis will soon be the leading cause of liver transplantation; creating a challenge for our country’s Health Care budget. The metabolic pathways that protect fatty liver disease’s progression to inflammation are under intense study. Recent findings provide evidence that abnormal hepatocyte cholesterol metabolism drives fatty liver’s transition to inflammation. StarD5, a unique protein involved in intracellular cholesterol movement and highly expressed in liver cells, appears able to provide an adaptive protective response; and may play a controlling role to protect the liver’s progression to inflammation in fatty liver disease. The proposal outlines a framework of studies to define this novel hypothesis; ones likely to unveil new pathways for pharmacological control of cholesterol/lipids and its associated pathologies.